Structure and Function of C. Difficile Toxins

Project Summary
Clostridium difficile infection (CDI) is the most common cause of antibiotic-­associated diarrhea
and gastroenteritis-­associated death among developed countries, and it is classified as one of
the top three “urgent threats” by the US Centers for Disease Control and Prevention (CDC). The
disease associated with CDI is mainly mediated by two homologous exotoxins, TcdA and TcdB.
They target and disrupt the colonic epithelium, leading to diarrhea and colitis. Receptor-­binding
is a critical step in the toxin’s action and largely determine toxin tropisms, and these receptors
are also molecular targets for therapeutic interventions. The goal of our proposal is to identify
and characterize toxin receptors, establish a structural basis for toxin-­receptor recognition, and
harness this knowledge to gain a mechanistic understanding of the biology, pathogenesis, and
therapy of TcdA and TcdB. We will take a multi-­disciplinary approach, bringing together the
expertise in toxin structure/function of Dr. Rongsheng Jin’s group with the expertise in toxin
receptor identification/pathogenesis of Dr. Min Dong’s group. This proposed work is built on
both our published work on identifying Frizzled (FZD) proteins as TcdB receptors, and extensive
preliminary data on toxin-­receptor interactions. We will focus on three aims: (1) elucidate the
structural basis and pathogenic relevance of TcdB-­FZD recognition;; (2) understand the structure
of TcdB and the influence of FZD binding;; and (3) identify and characterize novel TcdA
receptors through a CRISPR/Cas9 mediated genome-­wide screens. These proposed studies
will provide a comprehensive understanding of toxin-­receptor interactions and how they
contribute to the toxin biology and pathogenesis of TcdA and TcdB.

Public health relevance
Project Narrative Clostridium difficile toxin A (TcdA) and toxin B (TcdB) are responsible for diseases associated with C. difficile infection (CDI). Here we seek to identify the toxin receptors, establish a structural basis for toxin- receptor recognition, and harness this knowledge to gain a mechanistic understanding of the biology and pathogenesis of TcdA and TcdB.